Administrative Core

ADMINISTRATIVE CORE
Abstract
The administrative core will lead, manage, and support all activities of the Acquired Resistance to Therapy
Network (ARTNet) Center for Pancreatic Cancer (ACPC). It will represent ACPC at the trans-ARTNet network
activities, and in interactions with NCI. The ARTNet administrative core will be responsible for managing the
activities of the synergistic research ACPC projects with scientific and technical expertise and resources in the
areas of therapy resistance, signaling, metabolism, pancreatic cancer biology, organoid and mouse models,
immune and non-immune stroma, and PDAC tissues for studying the acquired therapy resistance in cancer. The
core leadership will provide expertise spanning the basic to translational spectrum, consistent with the
overarching theme of ACPC, with track records of building and guiding large scientific teams to successfully
advance fields in transformative ways. We will utilize strategic management with innovative approaches,
including an educational component to bring new talent into the field, engage diverse teams to facilitate new
ideas, leverage national talent pertinent to the proposed goals, engage university leadership in building support
for cutting-edge science, and utilize dedicated university expertise to facilitate engagement with basic and
translational research programs to grow ARTNet centric interests. The administrative core will provide support
for personnel involved in the administration, coordination, communication, biostatistics, and bioinformatics to
support the ARTNet activities within the center and campus, other ARTNet centers, ARTNet Coordinating Data
and Management Center (CDMC) and National Cancer Institutes (NCI). The administrative core will also provide
scientific oversight, result dissemination, budgetary oversight, and clerical functions associated with the overall
research program in this ACPC application. The core will implement center-wide activities which include,
developing new collaborations on the ACPC projects, organize annual retreat, support acquired cancer therapy
resistance seminar speakers within various academic units, advocate for the next generation of scientists
(graduate students, postdoctoral researchers, and junior faculty) in the ACPC member laboratories. Finally, the
administrative core will represent ACPC on the ARTNet steering committee.